Nathan Shock Centers of Excellence in Basic Biology of Aging (P30 Clinical Trial Not Allowed)

OVERALL – PROJECT SUMMARY
We propose this renewal application for the University of Washington Nathan Shock Center of Excellence in
the Basic Biology of Aging (UW NSC). The UW NSC has been a leader in providing innovative resources and
expertise to the geroscience community for over 30 years. The proposed center resources will continue this
history of high impact through outreach to connect investigators in the biology of aging with our set of highly
collaborative cores that offer state of the art technologies. These core services are centered around translating
complex high dimensional datasets, including multi-omics, into mechanistic insights into the biology of aging.
The Protein Phenotypes of Aging (Core C – Michael MacCoss and Judit Villen) provides advanced tools to
quantify how changes in the proteome, including turnover and stability, post-translational modifications, and
protein interactions, in addition to protein expression, drive aging biology. The Metabolic Phenotypes of Aging
Core (Core D – Daniel Raftery and David Marcinek) uses advanced mass spectrometry, NMR, and
mitochondrial assays to quantify changes in metabolism and signaling with age. Cores C and D provide tools
for generating and testing mechanistic hypotheses, as well as support for development of biological aging
clocks and biomarker analyses for clinical trials. The Invertebrate Models of Aging Core (Core E – Maitreya
Dunham and Alex Mendenhall) offers unique high throughput phenotyping, gene editing, and chemostat
technology to link high dimension data to whole organism (C. elegans) and cellular aging (S. cerevisiae). The
Explainable Artificial Intelligence (XAI) for Aging Core (Core F – Su-In Lee) provides a link between the three
other resource cores by applying and enhancing Dr. Lee’s novel XAI technology to move beyond black box AI
techniques to create biologically interpretable mechanistic insights from high dimensional and multi-omics data.
The Research Development Core (Core B – Jessica Young and Mariya Sweetwyne) will connect external
investigators and junior faculty to the UW NSC Resource Cores through support for traditional pilot projects (up
to $30,000 each) and RFAs for integrative pilots that involve multiple Resource Cores (up to $50,000 each).
Core B will also work to “build the bench” of new geroscientists by setting aside $10,000 to support 2-3
summer research projects in the basic biology of aging for undergraduates and high school students from
under-represented groups. The Administration and Program Enrichment Core (Core A – David Marcinek and
Jessica Young) will support the UW NSC with budget management, outreach and scientific direction through
coordination of external advisory boards, symposia and external speakers, training workshops for the
Resource Cores, and collaboration with other centers. Core A will also provide bioinformatic and statistical
support for rigorous experimental design and analysis for all UW NSC projects. Core A will also support a new
initiative to capitalize on the affiliations of the new UW NSC leadership to connect basic scientists to publicly
available databases from large cohort studies to facilitate testing the translational potential of mechanistic
insights from lab models to human aging.

Public health relevance
OVERALL – NARRATIVE We propose this renewal application for the University of Washington Nathan Shock Center of Excellence in the Basic Biology of Aging (UW NSC) to continue to build on its 30-year history of developing and providing cutting edge technologies, expertise, and leadership to the geroscience community. The proposed resources will have a high impact on research into the biology of aging by connecting investigators, particularly early career stage scientists, with our collaborative and integrated cores focused on translating high dimensional and multi-omics data into new mechanistic insights into the pathways driving aging and healthspan. Our four Resource Cores provide expertise and technologies in Protein (Core C) and Metabolic (Core D) Phenotypes of aging, Invertebrate Models of Aging (Core E), and Explainable Artificial Intelligence for Aging (XAI) (Core F); a Research Development Core (Core B) connects early-stage and investigators new to the field to our Resource Cores through a pilot program focused on integrating across cores and our Administration and Program Enrichment Core (Core A) supports statistical support, outreach, collaboration with other centers, program management, and oversight through an external advisory board.